Delivery of signaling and structural proteins to photoreceptor outer segment

DESCRIPTION (provided by applicant): The overall goal of this proposal is to integrate our mechanistic understanding of the signaling processes that take place in the outer segment of photoreceptor cells with the framework of the cellular processes responsible for maintenance of the protein composition of this organelle. To this end, Aim 1 will continue our longstanding investigation of the GTPase activating protein complex for transducin with an emphasis on the interplay between the cellular and catalytic aspects of its function. In Aims 2 and 3 a similar interplay will be analyzed for rhodopsin, which has three distinct roles in photoreceptor cells: signaling (activation of the phototransduction cascade), structural (building material of the disc membranes) and targeting (directing the flow of vesicles transporting rhodopsin and likely other proteins, e.g. the GTPase activating complex, to the outer segment). We will first test whether the role of rhodopsin in directing outer segment vesicular transport can be dissociated from its other major functions and then determine whether the structural function of rhodopsin can be replaced by other membrane proteins made to localize to the photoreceptor discs. Finally, Aim 4 will elucidate trafficking pathways responsible for the delivery of other proteins functioning in the outer segment. We will focus on a photoreceptor disc rim protein, peripherin-2/RDS, which is the most likely known candidate for using an intracellular targeting mechanism alternative to rhodopsin. The proposed experiments are relevant to understanding the most basic issues in photoreceptor cell biology and are key for understanding the causes of many types of photoreceptor degeneration associated with defects in protein signaling, targeting and trafficking.

Public health relevance
The studies proposed in this application address the molecular and cellular mechanisms responsible for the functioning of the light-sensitive compartment of the photoreceptor cells, the outer segment. Because of adverse effects of daily light exposure, the building materials of the outer segment have to be replaced approximately every ten days, which requires an enormous flow of highly organized protein trafficking from the intracellular biosynthetic machinery to this compartment. Dysfunction of these pathways causes some of the most severe types of inherited degenerative diseases of the retina, highlighting the importance of understanding the mechanisms underlying protein signaling, trafficking and assembly into large functional complexes. Elucidating these mechanisms is essential for developing strategies for disease prevention and future therapeutic interventions.